Decoding the beat: physiological control mechanisms for robust heart development

SUMMARY
A robust heartbeat is essential for vertebrate life, as it is critical for sustained transport of nutrients and waste
throughout large body plans. Given this fact, the emergence and maturation of cardiac activity during
embryogenesis must be extremely reliable and must be bidirectionally coordinated with development of the
heart’s form. The calcium physiology of the heart exemplifies this idea - it is the fundamental driver of cardiac
contraction by sarcomeric protein assemblies in each individual beat, but simultaneously triggers many signal
transduction pathways and induces gene expression. Here we will explore the changing patterns of cardiac
calcium signaling during embryonic development and investigate their implications for the heart’s maturation.
Calcium signaling contributes both to normal developmental processes and to disease in the adult heart,
suggesting that its tuning serves an important instructive role but must occur within a set of appropriate bounds.
Identifying these bounds requires definition of the precise rules that map cellular calcium to downstream outputs
during development. These rules have remained elusive because cellular calcium shows dynamics on the
timescale of hundreds of milliseconds, and spatial scales ranging from subcellular structures to entire tissues.
These patterns will evolve due to slower developmental processes, and their features that define reciprocal flows
of information can only be parsed in intact, live samples. I have established methods to image cardiac
physiological dynamics in tens of intact zebrafish embryos simultaneously, while administering non-destructive,
spatiotemporally programmable optogenetic control of these processes. My approaches open the door to an
unprecedented exploration of the high-dimensional signal encoding space traversed by calcium signaling in
cardiac development. First, we will develop all-optical approaches to measure calcineurin and
calmodulin/calmodulin kinase signaling in developing zebrafish hearts, record the dynamics of their behaviors
over normal development, and dissect response mechanisms with optogenetic reconstruction of cardiac calcium
physiology. Second, we will manipulate the physiology of developing zebrafish hearts and perform single cell
functional genomics to define a comprehensive list of calcium-sensitive developmental gene expression
programs. Finally, we will investigate the roles of cell type-specific calcium signaling mechanisms in cardiac
chamber specification. Together, these studies will define new rules by which the heart perceives its emerging
calcium physiology to make developmental decisions, tracing the basic biophysics of the cardiac cycle through
signal transduction, gene expression, and to organ-scale phenotype. In doing so, we will gain broader insight
into what delineates physiological versus pathological adaptation during cardiac development, and into
fundamental information-encoding mechanisms of calcium signaling which have been of longstanding interest
in disciplines as diverse as neuroscience, immunology, and regeneration.

Public health relevance
PROJECT NARRATIVE The maturation of form and function must proceed in lockstep for robust organ development, but the mechanisms of this coupling are with few exceptions understudied. Calcium dynamics are a prominent part of the heart’s physiology, and their dysregulation is implicated in cardiac disease, but their role in the progression of normal cardiac development is poorly understood. This proposal will investigate the encoding rules that map emerging calcium physiology of the embryonic zebrafish heart to downstream decisions important for its development, using innovative technologies for quantitative, spatiotemporally resolved measurement and control of cardiac physiology.